Fundamental properties of circadian rhythms

Project Summary
Molecular mechanisms of circadian rhythms generate autonomous oscillations that process external time
cues (e.g., light/dark cycles) that align temporal organizations of cellular and physiological processes to
external environments maximizing the survival of organisms. Defective or misaligned circadian rhythms
correlate with human diseases ranging from sleep disorders to cancer. The molecular circuitry of
circadian rhythms involves transcriptional and translational feedback loops (TTFL), which generate
autonomous oscillations of about 24 hours and subsequently regulate rhythmic cellular and physiological
events (e.g., timing of cell divisions, bowel movements, body temperature, etc.). In the past three decades,
extensive efforts have been made by numerous circadian biologists to identify core clock genes and their
transcriptional, post-transcriptional, and post-translational mechanisms that create a time-delayed
negative feedback loop. However, detailed molecular mechanisms that determine the period of circadian
rhythms and align the phase of the internal clock to external perturbations remain largely unknown. In
the proposed project, we will combine mathematical modeling, statistical uncertainty quantification
methods, and experimental validations to determine molecular mechanisms that determine the circadian
period and light-dependent phase shift of circadian rhythms. Successful completion of the proposed
project will lead to potential strategies to control, rescue, and phase shift circadian rhythms for
chronotherapeutic applications.

Public health relevance
Project Narrative Circadian rhythms are endogenous biological oscillators that process external time cues (e.g., light/dark cycles) and align temporal functions of numerous cellular and physiological processes with the external environment maximizing survival of organisms. The proposed work will uncover fundamental mechanisms that regulate the period and light-dependent phase shift of circadian rhythms, which will lead to potential strategies to modulate circadian rhythms for chronotherapeutic applications.